Reducing Maternal Delay Discounting as a Target Mechanism to Decrease Harsh Parenting and Improve Child Mental Health Outcomes in a Traditionally Underserved Community

Abstract
Harsh parenting is associated with serious and costly mental health problems among youth, including
substance use, mood disorders, and suicidal ideation and behaviors. Of concern, these parenting practices are
most common among families from impoverished communities; however, many behaviorally-based parenting
interventions do not take into account the unique mechanisms linking environmental disadvantage to parenting
approaches. While the causes of harsh parenting are complex and varied, one such mechanism may be
parents' tendencies to prioritize immediate rewards (such as stopping a child's misbehavior via physical
punishment like spanking and hitting) relative to larger, but delayed rewards (including improved parent-child
relationship quality). This behavioral tendency is known as delay discounting and recent findings from this
study team suggest that rates of delay discounting predict parents' use of harsh physical discipline. Existing
research also indicates a strong link between exposure to disadvantaged environments and the development
of delay discounting. Specifically, unstable and low-resource communities may reinforce opportunistic choice
behaviors, such that individuals exposed to these environments demonstrate an exaggerated tendency to
devalue rewards that are delayed in their receipt. Thus, delay discounting may be an important pathway linking
impoverished environments and harsh parenting. Utilizing an experimental therapeutics framework, the current
project aims to adapt an episodic future thinking (EFT) intervention to target the reduction of parenting-related
delay discounting. This application proposes to evaluate preliminary implementation and effectiveness
outcomes using a Hybrid Type I research design. Following a deployment-focused model, we will conduct
iterative small case-series trials and collect data from community-partners regarding necessary intervention
dosage and critical implementation outcomes (including acceptability, tolerability, and safety). Results from this
aim will inform manual adaptation. We will then recruit 72 mothers of children between the ages of 5 and 10
from community-serving organizations in the low resource, majority-minority, city of Flint, Michigan.
Participants will be randomized to receive EFT or a memory-focused comparison intervention. Outcomes will
evaluate the effect of EFT on reducing maternal delay discounting and harsh parenting, and improving child
clinical outcomes. Exploratory analyses will also consider the utility of the adapted intervention for improving
engagement and uptake of behavioral parent training techniques. Findings from this study will be used to plan
a large-scale (R01), Hybrid Type II intervention trial and will inform public health approaches for improving
youth mental health in vulnerable communities.

Public health relevance
Narrative Parents of children from impoverished communities are disproportionately more likely to engage in harsh physical discipline, which can lead to serious clinical outcomes, including suicidal ideation and attempts. One mechanism linking low resource environments and maladaptive parenting strategies is maternal delay discounting, or the tendency to value smaller, immediate rewards (such as stopping children's misbehavior via physical means) relative to larger, but delayed rewards (like improving the parent-child relationship). This study will examine the efficacy of implementing a low-cost, brief intervention targeting the reduction of maternal delay discounting to inform broader public health efforts aimed at improving adolescent mental health outcomes in traditionally underserved communities.